Restoring Cognitive Function through Precision Neurostimulation: A Disease-Agnostic Approach Based on Convergent Hippocampal Dynamics.

PROJECT SUMMARY
The hippocampus, a key part of our brain involved in memory and emotional regulation, often malfunctions in
many brain disorders, from developmental issues like autism to neurodegenerative diseases such as
Alzheimer’s Disease. This dysfunction can severely affect memory, social interactions, and overall quality of
life. Traditional treatments usually target specific disease-related changes at the molecular or protein level but
have had limited success. Our research aims to revolutionize this approach by focusing on the fundamental
brain activity patterns of the hippocampus. We propose that by correcting these disrupted activity patterns, we
can improve cognitive function regardless of the disorder’s cause. We will use six models of three common
neurological disorders to define similar abnormalities in brain activity across disease groups and examine
whether brain stimulation can improve both dynamics and performance in cognitive tests. We will extend this
approach with in-silico experiments that will model an extensive range of pathophysiological processes and
evaluate many more stimulation parameters than is currently feasible in biological models. Our iterative
approach that combines in-vivo and in-silico approaches is poised to accelerate clinical translation of our
studies. This new strategy could lead to groundbreaking treatments for a wide range of cognitive issues,
potentially benefiting millions of people. By using advanced techniques to understand and address these brain
activity disruptions, our work promises to pave the way for innovative therapies and better quality of life for
those with cognitive impairments.

Public health relevance
PROJECT NARRATIVE Hippocampal dysfunction, affecting memory, sociability, and executive function, is prevalent across various brain disorders and impacts millions of people. Traditional therapies targeting specific disease mechanisms have been largely ineffective, leading to a proposal for innovative neuroprosthetic interventions that address a fundamental disruption in neural network dynamics. This approach, focusing on normalizing action potential firing patterns through targeted stimulation, aims to provide a new, broad-spectrum treatment for cognitive impairments, potentially revolutionizing therapeutic strategies and benefiting millions worldwide.